CRL3KEAP1 complex licenses genotoxic stress-induced tumor cell death

PROJECT SUMMARY/ABSTRACT
This application is responsive to PA-17-449: The Interplay of Cell Death Pathways in Cancer Cell
Survival and Resistance to Therapy (R21). In general, genotoxic stress triggers apoptosis if tumor
cells express functional p53. Genotoxic stress can also induce p53 independent apoptosis due to
the auto-depletion of XIAP and cIAP1/2, which leads to the formation of “ripoptosome” complex.
Ripoptosome can stimulate caspase-8-mediated apoptosis. Mutated p53 and caspase-8 have
been frequently detected in human cancers. Caspase-8 mutation or inactivation often leads to
resistance to apoptosis. However, in a few cases, it renders cells highly susceptible to another
form of programmed cell death, termed “necroptosis.” Kinase RIPK3 and its substrate MLKL are
the critical players for necroptosis. Although several studies have indicated that DNA damage can
induce necroptosis (or undefined necrosis), the molecular mechanism is largely unknown. Herein,
we have used an unbiased genome-wide CRISPR knockout approach to identify new players in
DNA damage-induced necroptosis. We identified Cullin3 (Cul3)-RING E3 ubiquitin Ligase
(CRL3KEAP1) complex as a promising candidate that mediated DNA damage-induced necroptosis.
Our working model is that CRL3KEAP1 complex needs to degrade an unidentified substrate(s) to
let the progression of DNA damage-induced necroptosis, thus licensing genotoxicity-induced cell
death. We will make efforts to test this hypothesis in this proposal. We will determine what the
CRL3KEAP1 substrate(s) is(are) and how it(they) can halt cell death. The proposed studies will
provide new mechanistic insights on DNA damage agents induced cell death. Our ongoing efforts
have the potential to change how we trigger cell death in tumors, especially in those with p53,
caspase-8, and/or KEAP1 mutations.

Public health relevance
PROJECT NARRATIVE Evasion of cell death is one of the mechanisms contributing to tumor progression, metastases and resistance to therapy. The proposed studies will help to understand how DNA damage-based reagents can kill tumor cells via necroptosis, a form of programmed necrosis. Our study will offer specific mediators of necroptosis that can be targeted to redirect the resistant cancer cells toward effective cell death.